RENAL GROWTH MODULATION BY G-ALPHA-12 PROTO-ONCOGENE

Heterotrimeric guanine nucleotide binding (G) proteins composed of individual alpha, Beta and gamma subunits plays pivotal roles in the cellular physiology. It has recently been shown that pertussis toxin sensitive G-proteins, particularly the Gai-2 isoform, have a key role in number of growth pathways as well as in development. Recently mutations converting Gai-3 to an oncogene have been found in a number of tumors of endocrine origin. Wilms' tumor accounts for almost all childhood renal neoplasms. In a subset of this tumor as well as in individuals with Denys-Drash syndrome whose phenotype also includes male pseudohermaphroditism and glomerulosclerosis, mutations disable a transcription factor, WTI which is presumed to play a role in normal renal mitogenic and differentiating pathways. Although WTI has a known DNA binding sequence CGCCCCCGC, its target genes in renal cells have not been identified. In this proposal we provide evidence that Gai-2 subunit protooncogene is a target gene as its 5' flank contains a regulatory region in which Egr-l binding enhances gene transcription and WTI repress it. Also i this short DNA regulatory segment, a "CCAAT" box participates in a negative feedback pathway for adenylyl cyclase where increased cAMP production increases gene transcription for the inhibitory Gai-2 subunit. The long term goal of this proposal is to understand the role and regulation of Gai-2 renal epithelial cell growth and development. The specific aims include (1) clarifying the role of Gai-2 in renal cell growth as well as the mechanism of inducing this effect, (2) sorting out the respective roles of Egr-1 and its competitive respessor WT-1 in the regulation of Gai-2 gene expression in renal cells and (3) investigating the cAMP inducible "CCAAT" factors an how they interact with WT1 and Egr-1. These studies are likely to provide new insights into growth pathways contributory to the induction of Wilms' tumor and glomerulosclerosis. Furthermore, as Gai-2 is likely to regulate cell division and growth, we should gain insight into the processes by which the kidney responds to injury and hypertrophy.